Enhancing antitumor efficacy by intratumoral delivering LAIR1 inhibitory signaling

PROJECT SUMMARY
Recent evidence suggests that tumor-associated myeloid cells (TAMCs), which include tumor-associated
macrophages (TAM) and myeloid-derived suppressor cells (MDSC), play a significant role in cancer
immunosuppression and progression. These cells constitute up to 50% of the tumor's total mass in glioblastoma
(GBM) and play pivotal roles in dampening the immune response, thereby negatively affecting patient survival.
Therefore, targeting TAMCs could overcome the limitations of current cancer treatments. Yet, drug development
in this realm remains limited. Our research focuses on leukocyte-associated immunoglobulin-like receptor 1
(LAIR1), prominently expressed on the surface of TAMs, which is essential in mediating the immunosuppressive
role of TAMs. We have uncovered a previously unrecognized immunosuppressive LAIR1→ Factor XIII A (FXIII-
A) → Collagen IV circuit across cancer types. The LAIR1 triggers TAMs to release the FXIII-A around tumor
cells, which increases tumor collagen IV deposition and structure, shielding the tumors from immune attacks.
Inhibiting LAIR1, either through genetic knock-out (LAIR1-/-) or antibody blockade (aLAIR1), effectively disrupts
this immunosuppressive pathway and results in enhanced peripheral and tumor-infiltrating memory CD8 T cell
populations, a phenotypic shift of TAMs towards an M1 profile, and a decrease in collagen deposition. These
collective effects contribute to the normalization of the TME and facilitate improved interactions between T cells
and tumor cells, leading to a more effective antitumor response. Notably, using aLAIR1 as a standalone
intervention or combined with Chimeric antigen receptor (CAR) T cell therapy demonstrates enhanced antitumor
efficacy in preclinical models resistant to anti-PD-1 treatment. These findings position aLAIR1 as a promising
strategy for cancer immunotherapy. We hypothesize that LAIR1 is a new inhibitory immune checkpoint molecule
that controls the pro-tumor function of the TAMCs.
This study will elucidate mechanisms of the signaling axis of LAIR1 and its binding partners in tumor
immunosuppression and progression and determine if inhibiting this molecule using 3-in-1 triple-functional CAR
(L2-8R-70CAR (targeting tumor cells, enhancing CAR T cell tumor trafficking, and delivering LAIR1
blocking to TAMC inhibition) can reshape the tumor microenvironment and induce a profound antitumor response.
Two aims are proposed: Aim 1: Determine the role of LAIR1 in GBM immunosuppression. Aim 2: Overcome the
blood-brain barrier (BBB) using our 8R-70CAR T cells, currently being tested in a phase I clinical trial (FDA-
IND#23881, NCT05353530), to deliver LAIR1 inhibitory signaling in GBM.
Successfully completing this study will advance our understanding of the LAIR1 signaling axis and its role in
tumor immunosuppression and progression. It will validate the use of 3-in-1, L2-8R-70CAR T cells in overcoming
the blood-brain barrier to deliver targeted LAIR1 inhibition and demonstrate the potential of triple-functional CAR
T cells to reshape the tumor microenvironment and induce a robust antitumor response.

Public health relevance
RESEARCH NARRATIVE This study will provide vital information on a novel immune checkpoint, the LAIR1 signaling network in cancer, and determine how its blocking strategy using the CAR T cell-delivering system (3-in-1) affects the efficacy of cancer immunotherapy in GBM, ultimately leading to improved cancer treatment outcomes in clinical settings.